BRAIN CONNECTS: Photoemission Electron Microscopy for Connectomics

We propose to develop a new microscope for connectomes with the potential to reduce the
price of a connectomic voxel by order(s) of magnitude. We will focus on a relatively unexplored
type of EM microcopy based on excitation of photoelectrons by UV light and their detection
with standard widefield EM optics (PEEM). Simply, PEEMs for connectomes can combine the
reliability of SEM imaging with the thruput of TEM imaging. We have demonstrated for the first
time that PEEMs can see synapse and we have designed a tailored PEEM microscope with
strong UV excitation from lasers and direct EM detectors that can work at Gigahertz imaging
rates. We will explore collecting 1000s of ultra-thin brain slices (UTBS) using two state of the art
automated approaches, the ATUM and Mag-C. We will optimize this pipeline, extending our
current sample preparation to support such imaging rates, adding Gas Cluster Ion milling to
improve the Z-resolution of PEEM connectomes, and, by designing, developing, and integrating
a new generation of fast stages that keep up with imaging rates. Finally, we will instantiate auto-
acquisition and quality assurance algorithms, e.g., auto-focus, auto-sigmate, etc. to facilitate
the imaging and collection of 1000s of ultrathin brain sections. We provide clear metrics for
success and achieving those milestones, we argue, could revolutionize how EM conenctomes
are made.

Public health relevance
In this proposal, we will develop and vet a new type of EM microscope for connectomics with the potential to revolutionize how connectomes are made. This microscope will democratize connectomes, making them cheaper and faster, and enabling full connectomes of mouse brains, and with further optimization, non-human primate, and human connectomes.